Administrative Core

Project Summary/Abstract: Administrative Core
This Center brings together a truly diverse team of biomedical, chemical/combustion engineers and physicists,
and non-technical researchers and support staff to conduct interdisciplinary research examining the
environmental and health impacts of pollutant particle systems formed during thermal treatment of hazardous
wastes. The driving scientific concept and innovation of this Center focuses on these environmentally
persistent free radicals (EPFRs). Our team is comprised of experts from Louisiana State University (LSU), LSU
Health Sciences Center in New Orleans, LSU School of Veterinary Medicine, North Carolina State University,
Dominican University of California, and University of Queensland, Australia. All participating institutions have
invested in the success of the Center and have agreed to offer significant additional support, which will be used
to provide flexibility for our Center to respond quickly and effectively to new opportunities, pursue high-
risk/high-impact and transformative research, and attract new faculty/researchers as participants. The
Administrative Core (AC) will monitor, prioritize, allocate, and manage resources across these sites. This
includes fostering efficient collaboration, data and information sharing, the rapid dissemination of resources,
evaluation and management of programmatic performance, and the identification and resolution of problems.
Innovations include meetings structured to disseminate information across Project and Cores to stakeholders,
leveraging of state-of-the-art institutional resources (e.g., LSU’s Center for Advanced Microstructures &
Devices and Materials Characterization Laboratory; LSUHSC’s Statistical Analysis Core; LSUSVM’s Inhalation
Research Facility) and development of a web portal (managed by the DMAC and AC) for archiving, sharing
and analysis of all data generated by the Center. The integration of Research Translation (RT) into the Core
creates opportunities for even greater cross-Center collaboration and bidirectional RT. The RT component of
the Core will work with the Research Experience and Training Coordination Core and Project and Core
Leaders to involve trainees in community engagement activities and provide professional development
workshops on concepts related to environmental health science and Center research. The RT component will
establish new and strengthen existing community, industry, governmental, and SRP partnerships by inviting
partners to participate in Center activities, such as the annual Dellinger Symposium. Finally, LSU’s Office of
Research & Economic Development has created a supportive environment for multidisciplinary research
initiatives such as our Center offering centralized officers for compliance (IRB, IACUC, etc.), facilitating
/organizing scientific reviewers for the application, and assisting with the editing and compilation of this
proposal. The Center has and will continue to use feedback from the External Advisory Committee, which is
comprised of experts from our various research fields and from the community and other stakeholders to fulfill
the missions of NIEHS and the Superfund Program Mandates.

Public health relevance
Project Narrative: Administrative Core Environmentally persistent free radicals (EPFRs) are pollutant-particle systems emitted from thermal treatment technologies, or wind-blown dusts created during remediation and containment activities of Superfund wastes. Our research has shown that inhalation exposure to EPFRs elicits cardiac and pulmonary dysfunction. The Administrative Core supports the program’s goals by providing a cohesive administrative structure to manage the diverse aspects of the Center and ensuring that our data improves public health by guiding site remediation, decision-making, and environmental policy.